Core A: Administrative

Abstract
The UW/Fred Hutch CFAR Administrative Core leads our consortium and is responsible for strategic planning
and operational management. The Aims of the Administrative Core are to: 1) Create a strategic vision and a
multidisciplinary and collaborative environment, to enable conduct of the best science, growth of the next
generation of HIV researchers and research leaders, and achieving impacts that will bend the curve of the global
epidemic and 2) Deliver efficient, effective, timely, compliant, and collegial operational management to add value
to the HIV research enterprise at our CFAR. In support of these Aims, the Administrative Core has proposed
the following Goals, linked to our two Aims: 1a) Support our Cores, SWGs, and partners to reach across
disciplines and institutions; 1b) Implement and continuously refine our CFAR strategic plan; 1c) Provide an
environment to grow collaboration and respond to emerging needs, opportunities, and scientific priorities, 1d)
Actively participate in inter-CFAR initiatives and bi-directional connections to the community; 2a) Manage the
CFAR and its grants, finances, and personnel according to robust principles, policies, and procedures; 2b) Grow
funding, facilities, and other resources for HIV research; 2c) Provide educational and research training
opportunities; and 2d) Effectively advertise and promote utilization of CFAR services. The Core works across
our collaborating institutions to achieve these goals, including with: the President, Provost, and Dean of the
School of Medicine at the University of Washington, the President of the Fred Hutchinson Cancer Research
Center, and CEOs of affiliated institutions, obtaining substantial institutional commitment of funding and space
to grow the work of the CFAR and CFAR members; the University of Washington Department of Global Health,
where the Administrative Core is based, to facilitate and leverage efficient and effective grant administration and
operational support for our investigators; research centers and institutes within our organizations, to catalyze
new research and support robust existing programs; local, state, and federal agencies, in Washington and
beyond, and international partners, to achieve impact at scale in the prevention and treatment of HIV; community-
based organizations for collaborative leadership and engagement; and with other CFARs to synergize with the
larger CFAR mission. Key innovations in the Administrative Core for this proposed cycle include our new Director
and Leadership Team, integrated administrative functions across Cores, updated plans for communications and
outreach for CFAR services, collaborative outreach of our Community Action Board (CAB), and a validated
approach to monitoring and evaluation. As described in the Overall Research Strategy, our CFAR's overarching
Vision is to ensure an enabling environment to facilitate cutting-edge research for our 700+ multidisciplinary
investigators and growth of the next generation of HIV leaders, who will make a meaningful impact on the global
epidemic. The Administrative Core provides effective, efficient, and strategic leadership and management to
bring together our entire CFAR to achieve this vision.